Scaling Out S.A.F.E. Firearm Across Two Health Systems As A Universal Suicide Prevention Strategy

Reducing access to firearms, a modifiable risk factor present in 40% of homes in the United States, is a
population-level suicide prevention strategy. S.A.F.E. Firearm is a universal evidence-based suicide prevention
intervention primed for implementation nationally. In the largest hybrid type III effectiveness-implementation trial
of its kind, funded by NIMH (“ASPIRE” trial), we tested how to implement S.A.F.E. Firearm across 45,000 well-
child visits in 30 pediatric primary care clinics at Henry Ford Health (HFH) in Michigan and Kaiser Permanente
Colorado (KPCO). We found that training, an electronic health record (EHR)-based clinician decision support
(“nudge”), and facilitation (i.e., implementation support to clinics) resulted in robust practice change from 3%
reach (baseline) to 54% reach (active implementation). While the ASPIRE trial focused on delivery of the
intervention to parents of young people, we have the rare opportunity to expand S.A.F.E. Firearm delivery for all
adults via adult primary care and women’s health clinics, offering a new context and broadened population. This
holds promise given that (a) many of these patients will have children in their homes (e.g., parents, grandparents)
and (b) adults may benefit from S.A.F.E. Firearm themselves because putting time and space between adults
and loaded firearms can reduce firearm suicide. The proposed study (“SCALE-ASPIRE”) is motivated by HFH
and KPCO constituents’ eagerness to implement this intervention beyond pediatric primary care and will advance
the science of implementation by understanding how to “scale-out” successful intervention and implementation
efforts. In SCALE-ASPIRE, we will conduct a stepped wedge cluster randomized hybrid type II effectiveness-
implementation trial in 48 clinics in adult primary care and women’s health at HFH and KPCO. In Aim 1, in
collaboration with key partners including clinicians, leaders, and patients, we will use the ADAPT-ITT approach
to adapt S.A.F.E. Firearm for the new clinic context and broadened population. In Aim 2, we will test the
effectiveness of S.A.F.E. Firearm and our implementation approach (training, EHR nudge, facilitation) on
effectiveness (firearm storage behavior, co-primary; suicide attempts, suicide deaths, and all-cause firearm injury
and mortality in adults and young people, secondary) and implementation (reach, or patient-reported receipt of
S.A.F.E. Firearm, co-primary; implementation fidelity and cost, secondary) outcomes. In Aim 3, we will use mixed
methods to elucidate intervention and implementation mechanisms and to better understand heterogeneity
across levels, with a focus on equity. Specifically, we will conduct interviews to understand constituent
perspectives, and explore how patient, clinician, and clinic factors relate to heterogeneity in our co-primary
outcomes. Study results will guide the identification of effective secure firearm storage interventions, increase
knowledge of effective implementation strategies in large health systems, and advance the literature on scaling-
out successful intervention and implementation efforts to new populations and settings, in line with Firearm Injury
and Mortality Prevention Research, NOT-OD-23-039.

Public health relevance
PROJECT NARRATIVE S.A.F.E. Firearm is a universal population-level evidence-based suicide prevention intervention that is ready for implementation in health systems across the United States, but delivery to date has focused on parents of young people, including its successful implementation by our team in pediatric primary care in two large health systems in Michigan and Colorado. There is an opportunity to extend the reach of this intervention: in response to constituents from the two health systems clamoring to implement this intervention beyond pediatric primary care, we propose to adapt, implement, and evaluate the effectiveness of S.A.F.E. Firearm in adult primary care and women’s health in the two health systems. The proposed project will help us better understand how to “scale-out” this successful intervention to a broadened population and new setting, and importantly, strives to prevent firearm suicide and all-cause firearm injury and mortality in adults and young people.